Computational Core

ABSTRACT– COMPUTATIONAL CORE MODULE
This module is a response to the growing demand for integrating computational and experimental work. Funding
agencies are increasingly looking for rigorous computational aims to complement experimental goals, and high
impact factor journals often require a model to explain experimental findings. By providing consulting, education,
and collaborations on computational techniques to complement existing research in the department, this
computational core will encourage and accelerate adoption and incorporation of state-of-the-art computational
and statistical approaches to ongoing fundamental biological research. The module includes servers for data
storage and computing (approximately 200TB of storage capacity annually).